Kappa Opioid Receptors and Phospho-Dopamine Transporters Drive Cocaine Reward

SUMMARY
Substance use disorder afflicts nearly one in seven people in the US, placing a heavy burden on healthcare
resources, the economy, and individual quality of life. Currently, there is no effective medication available for
cocaine use disorder (CUD), most likely because the neurobiology underlying the disease is complex and not
completely understood. Dopaminergic neurotransmission in the mesolimbic circuit has been shown to play a
critical role in CUD. Cocaine inhibits the activity of the dopamine transporter (DAT) to produce its behavioral
effects. Regulation of the DAT, a principal regulator of dopamine signaling, occurs primarily through post-
translational modifications, such as phosphorylation, which are triggered by presynaptic auto and hetero-
receptor-linked signaling cascades. These modifications alter the interaction of cocaine with the DAT, leading
to changes in the stimulating and rewarding effects of cocaine. However, to date, post-translational
modifications have not been a focus of investigation in the CUD field. Our studies show that phosphorylation of
the Threonine-53 residue of DAT, or phospho-T53-DAT (PT53-DAT), plays a pivotal role in regulating cocaine-
directed behaviors. In this proposal, we explore this novel finding using cutting-edge techniques, including a
knock-in mouse model with a phosphorylation-defective DAT-Thr53Ala mutant (DAT-A53), a viral-mediated
brain region-specific blockade of DAT-T53 phosphorylation, and fiber photometry-based measurements of
dopamine in freely moving mice using the fluorescent sensor, dLight. With these new models and tailored
biochemical, neurochemical, and behavioral studies, the current proposal aims to fill a critical gap in our
understanding of the central role of DAT phosphorylation in normal dopamine neurotransmission and in the
presence of cocaine, including in live animals for the first time. As a key mechanism, we have discovered that
the kappa-opioid receptor (KOR) regulates DAT via PT53-DAT. Our studies also show that KOR activation
increases DAT activity through PT53-DAT, and when T53 is substituted with A53, the aversive effects of a KOR
agonist are attenuated. Here, we will expand and test our overarching hypothesis “Cocaine induces addiction-
like behaviors when the KOR phosphorylates DAT at T53 and alters DA dynamics”. Aim 1 will investigate the
effect of T53 phosphorylation on KOR-mediated DAT upregulation, trafficking and protein-protein interactions.
Aim 1 will also examine if these PT53-DAT-dependent effects are sex-, and brain-region specific. Aim 2 will
examine the impact of PT53-DAT on extracellular DA dynamics and DA release and clearance modulation by
KOR and cocaine in vivo and in brain slices. Aim 3 will determine whether PT53-DAT plays a role in KOR- and
cocaine- associated behaviors. Outcomes from the proposed studies will provide novel insights into the
mechanisms of CUD, open new horizons for examining phosphorylation of DAT-T53 as an underlying
mechanism of dynorphin actions in DA-signaling and cocaine addiction and expose new molecular therapeutic
intervention points.

Public health relevance
NARRATIVE Cocaine use disorder is a serious problem in today’s society, and there are no effective therapeutics available. Stress is known to increase cocaine relapse vulnerability, and we posit that a major component of the endogenous stress system, the kappa opioid receptor, underlies stress-cocaine interactions. This proposal explores the potential of blocking kappa opioid receptor-induced phosphorylation of one protein, the dopamine transporter, which is the primary target of cocaine, in reducing the rewarding effects of cocaine and drug- seeking behavior.